Angiopoietin/Tie signaling regulation of vascular leakage in lung inflammation

Angiopoietin/Tie signaling regulation of vascular leakage in lung inflammation PROJECT SUMMARY As a central feature of acute lung injury and acute respiratory distress syndrome (ARDS), vascular leakage not only impairs gas exchange but also initiates a cascade of events that can have fatal consequences. No treatments are currently available to reduce leakage by stabilizing the lung vasculature. This project will determine the contributions of angiopoietin-2 (Ang2), orphan receptor Tie1, and VE-PTP, also known as vascular endothelial protein-tyrosine phosphatase, to the regulation of Tie2 (Tek) receptor signaling and increased vascular permeability (“leakage”) in lung injury. Building on known anti-leakage effects of angiopoietin-1 (Ang1) and other Tie2 agonists, the project will target components of a recently described positive feedback loop that governs the severity of vascular leakage. Inflammatory cytokines that trigger Tie1 receptor ectodomain shedding and inactivation and Tie2 signaling suppression in endothelial cells also increase Foxo1 transcriptional activity and expression of Ang2, which sustains Tie2 inactivation and leakage. Aim #1 will explore new approaches for reducing leakage and promoting vascular stability in lung injury by reversing the suppression of Tie2 signaling in endothelial cells of alveolar capillaries. Experiments will determine the contributions of Ang2 overexpression, Tie1 ectodomain shedding and inactivation, and VE-PTP- mediated Tie2 dephosphorylation to Tie2 inactivation and leakage in lung injury. Genetic and pharmacologic gain- and loss-of-function strategies will be used to activate Tie2, inhibit Ang2, suppress Tie1 ectodomain shedding, and inhibit VE-PTP activity in the lung vasculature in prevention and reversal trials of sepsis and influenza virus infection in mice. Tie1, Tie2 phosphorylation, Ang2, VE-PTP, and leakage will be assessed as readouts. Leakage will be localized and measured by novel methods for visualizing extravasated fibrinogen and 20-nm fluorescent microspheres at the level of individual alveolar capillaries. Aim #2 will examine the functional and prognostic significance of elevated circulating levels of soluble Tie1 (sTie1) as a biomarker of endothelial dysfunction in lung injury. Studies in mice will identify changes in endothelial cell Tie2 signaling that lead to increased blood levels of sTie1 and how these relate to the severity of leakage from lung capillaries. Parallel studies of critically ill patients will probe the clinical significance of elevated plasma levels of sTie1 in sepsis, with or without the development of ARDS. The work will build on data from pilot studies showing 67% mortality in 23 critically ill patients with elevated plasma levels of sTie1 and Ang2 at admission, compared to only 8% in those with normal sTie1 and Ang2. Together, the experiments will define the functional benefit of activating Tie2, inhibiting Ang2, suppressing Tie1 ectodomain shedding, and inhibiting VE-PTP in lung injury, and will determine the clinical significance of sTie1 as a prognostic biomarker in ARDS.

Public health relevance
Angiopoietin/Tie signaling regulation of vascular leakage in lung inflammation PROJECT NARRATIVE Vascular leakage in the 200,000 annual cases of acute lung injury and acute respiratory distress syndrome (ARDS) in the US not only impairs gas exchange in the lungs, but also initiates a cascade of events that can have fatal consequences. Activation of Tie2 receptor signaling by angiopoietins has potent anti-leakage effects and is among the most promising approaches for stopping leakage by stabilizing blood vessels. Through studies of mouse models of disease, the project will advance the mechanistic understanding of manipulating Tie2 signaling pathway components as a strategy for reducing vascular leakage in lung injury, and through studies of critically ill patients, the project will determine the clinical significance of circulating Tie1 receptor ectodomain in blood as a biomarker for monitoring disease severity in ARDS.